PROSPECTIVE RANDOMIZED EVALUATION OF DYNAMIC CARDIOMYOPLASTY

We enrolled one patient into this protocol during this time period. He was randomized to the surgical treatment arm. This multicenter study is still ongoing.